Neural Stimulation to Enhance Community Mobility after Incomplete SCI

The long-term objective of this project is to improve the walking speed and stability Veterans disabled by
incomplete SCI (iSCI) sufficiently to safely participate in community activities outside of the home, and thereby
enhance their independence and daily function. We will advance this goal by developing and implementing
new, practical, and readily customizable control systems for peripheral nerve stimulation to augment the
actions of selected weak or paralyzed muscles based on real-time feedback of voluntary body movements.
Ten subjects representing a cross section of individuals with difficulty walking due to iSCI will undergo
conventional gait training prior to serving as their own controls in a series of single-subject research studies
with and without our stimulation controllers active. The proposed controller will process inputs from a small set
of body-mounted sensors to guarantee that stimulated assistance works together with intact movements to
automatically advance the body forward, intuitively vary walking speed, and take corrective forward or
sideways steps to recover from unexpected and potentially destabilizing disturbances. By the end of the study,
six of the participants will have received such gait assist systems consisting of our current implanted
stimulators and externally worn sensors. The resulting knowledge with prepare for clinical translation via
surface-based or completely implanted stimulation and sensing systems, such as the soon to be available
Networked Neural Prosthesis System currently undergoing pivotal trials for marketing approval. Our aims are:
1) Develop and implement a stimulation control system based on estimates of movements of body Center of
Mass during walking from a small set of wearable sensors. Transitions between patterns of stimulated
assistance to the specific set of weak or paralyzed muscles most responsible for the individual gait
difficulties of each subject will be made automatically to keep the body moving forward dynamically.
2) Adapt the timing and intensity of stimulation automatically alter walking speed from those sufficient for
household ambulation (<0.4m/s) to those required to function in the community (>0.8m/s). A control
algorithm will facilitate intuitive modulation of gait speed by adjusting stimulation during the next step to
match the movements of the body generated by the volitional actions of the intact muscles sensed during
the current and immediately previous steps.
3) Finally, we will counteract large and potentially destabilizing perturbations to the Center of Mass by
interrupting continuous walking and a generating a forward or sideways protective step to prevent losses of
balance and maintain standing posture. Inputs from the same wearable sensors sensitive to the Center of
Mass will be interrogated to detect sudden disturbances to trigger the reactive steps in the appropriate
direction and facilitate recovery. This represents the first time such mechanisms will be explored as a
protective measures during stimulation assisted walking.
This study is an important next step toward preparing wider scale application in larger clinical trials of the gait
assist system in via a VA Translational Rehabilitation Research Award or the Cooperative Studies Program. It
will determine whether the new control algorithms we propose are customizable to individuals with iSCI with a
variety of impairments, are easy to set up and intuitive to use, and improve walking function and overall activity
levels, and engender confidence and reduced fear of falling. Successful completion of this project will define a
new intervention for Veterans with difficulty walking due to partial paralysis from iSCI, thus enabling them to be
independent ambulators and accelerating their access to life opportunities as active participants in their
communities and society at large.

Public health relevance
The overall goal of this project is to enable Veterans with partial paralysis due to incomplete spinal cord injury (iSCI) to improve their daily walking capabilities and become functional ambulators in the home or community environments. Approximately 15% of all Americans with SCI are Veterans, and the number of new cases with iSCI has been outpacing all others. We will achieve the goal of enhancing the functional walking ability and overall activity level of Veterans with iSCI by developing practical methods to control the activation of paralyzed or partially paralyzed muscles and seamlessly coordinate them with voluntary contractions to propel and stabilize the body based on feedback from wearable sensors that can estimate movement of the user's center of mass. This study progresses from initial computer simulations, through preliminary laboratory experiments, to clinical implementation with 10 volunteers with iSCI needing various degrees of stimulated assistance to walk naturally, intuitively vary walking speed, and recover from potentially destabilizing disturbances.